Nonhuman Primate Antibody Resource for Immune Cell Depletion

Project Summary – Overall
Nonhuman primates (NHPs) have historically served as crucial animal models for diseases and for testing new
therapies and vaccines that cannot be evaluated in small animal models. The utility of NHP models in research
has been enhanced considerably by the use of immune cell-depleting antibodies that can target and lyse specific
cell subsets in vivo. In models of infectious disease and vaccine testing, targeted immune cell depletion has
been used to understand the pathogenesis of these infections and to design better vaccines to prevent them.
Furthermore, immune cell depletion can be an effective immune-modulating therapy and the preclinical testing
of these cell-depleting antibody drugs is often conducted in NHPs. Our P40-funded Center, “Nonhuman Primate
Antibody Resource for Immune Cell Depletion,” has been a major source of immune cell-depleting antibodies
for the scientific community, and our vital reagents have enabled NHP studies in fundamental, biomedical, and
preclinical research.
For the past 24 years, NIH has supported the Nonhuman Primate Reagent Resource’s efforts to develop,
characterize, manufacture, and distribute immune cell-depleting antibodies for use in NHP models through an
R24, which was then superseded by this and a P40 grant. The need for this program has been confirmed by the
growth in program activity since its inception. Over the past 5-year cycle (2018-2022), this grant fulfilled 547
reagent requests to 139 investigators from 95 institutions. These reagents were cited in 73 publications and
supported 226 NIH grants or programs. Nearly 1.16 kilograms of 14 distinct antibody reagents were distributed.
In this P40 renewal, we propose to continue to support the scientific community by maintaining the large-scale
manufacture and quality control of immune cell-depleting and control antibodies for use in NHPs. We will also
develop and optimize antibodies against new high-priority NHP targets identified by the scientific community, via
our outreach strategy and development request web portal tools. The reagent development will be prioritized by
our External Advisory Board. Our established, secure web-based infrastructure will continue to be used for
advertising reagents, receiving and fulfilling requests, and measuring program effectiveness through surveys
and an interactive dashboard. In the proposed funding cycle, we will institute a new Curation and Informatics
Component that will be dedicated to curating, tracking, distributing, and promoting the Center’s reagents. The
Curation and Informatics Component will also be responsible for maintaining and upgrading the web portal to
increase our alignment with FAIR and TRUST guidelines. Our vision is that our Center will not only generate
invaluable reagents but will also enhance rigor and transparency in the use of our reagents to improve
reproducibility. Finally, we will conduct applied research to develop a new antibody ‘primatization’ method to
improve the performance of our depletion therapies in NHP studies. This award funds unique NHP cell-depleting
antibodies that are indispensable tools to hundreds of NIH grants.

Public health relevance
Project Narrative – Overall Nonhuman primates (NHPs) play an essential role as animal models of human disease in basic biomedical and translational research. The Nonhuman Primate Antibody Resource for Immune Cell Depletion develops, manufactures, and distributes immune cell-depleting antibody research reagents to enable critical studies in NHPs. These immune cell-depleting antibodies help investigators develop treatments and vaccines for many different infectious diseases and improve organ transplantation methods.